Feeding interaction network analyses enhance management of NHP breeding groups

Abstract
A primary mission of Animal Resources Divisions at National Primate Research Centers (NPRC) is to maintain
the overall social health of Indian-origin rhesus macaques (Macaca mulatta) living in large multi-generational
breeding groups in order to ensure the availability of high-quality research subjects for NIH-funded research.
The social dynamics of these breeding groups, however, are complex and disturbances in their dominance
hierarchy and kinship structures can lead to increased aggression and fighting that may result in significant
wounding. Thus, a common challenge in their management is the utilization of effective social heath surveillance
methodology to identify groups at risk for social instability before the onset of significant fighting. These captive
groups are routinely monitored for changes in dominance ranks and rates of trauma to detect social instability at
the family- and group-level; however, the precise timing of severe outbreaks of aggression is largely considered
unpredictable. Further, the frequency of interactions that define dominance and affiliative relationships in these
groups are sparse; thus, the gathering of enough behavioral data to unequivocally detect social instability is time-
consuming. We recently published a report that indicated automated feeding data can provide critical real-time
data and assist management with monitoring social stability in rhesus macaque breeding groups, by possibly
predicting the timing of intense aggression. The purpose of this proposal is to expand upon these observations
by establishing data-driven models that help management identify groups at risk for social instability. Because
automated feeding data include precise timestamps and the order in which animals feed, network analyses can
be used to construct Feeding Interaction Networks (FINs), allowing us to examine patterns of temporal proximity
feeding among kin and non-kin. Because reproductive status also influences food intake in female monkeys, we
will study six outdoor breeding groups at the Yerkes NPRC across the breeding and birthing seasons, and
integrate social and reproductive data, with the overarching aim to develop comprehensive data-driven FIN
models that will enhance colony management practices of NIH-supported rhesus macaque breeding colonies.
Aim 1 will characterize the community structures within static FINs of rhesus macaque breeding groups, varying
in size and composition. Aim 2 will determine whether the directionality and strength of connections between
adult females within a static FIN can be used to predict patterns of affiliative and dominance relationships among
kin and non-kin. Aim 3 will quantify and model the temporal changes of community structures within dynamic
FINs of rhesus macaque groups across the breeding and birthing season with respect to female reproductive
phase. Finally, Aim 4 will detect changes in the community structures of dynamic FINs, not associated with
reproductive seasonality, that are precursor to increased aggression and other signs of social instability. These
FIN models will be used to supplement behavioral and trauma data, allowing management to identify groups at
risk for social instability and develop strategies to intervene prior to the escalation of additional aggression.

Public health relevance
Narrative The primary goal of this project is to use network analyses to construct a Feeding Interaction Network using automated feeding data collected from animals living in large breeding groups at the Yerkes National Primate Research Center. If successful, these models will identify groups at risk for social instability before the onset of fighting and injury. The application of automated feeding data in the social management of captive colonies of rhesus macaques represents a paradigm shift from more conventional practices.